Mechanisms of Stem Cell Regulation during Tissue Renewal and Cancer Development

Project Summary/Abstract
Tissue renewal is essential for long-lived organisms such as humans. Billions of cells are replaced daily in the
human body; paradoxically, this constant cellular turnover of aging and damaged cells provides recurrent
opportunities for cancer development. Indeed, over 90% of human cancers originate in epithelial tissues that
undergo frequent renewal throughout life. However, studying cellular transformation during tissue renewal is
challenging as it involves asynchronously different turnover rates (e.g., skin and intestinal epithelia). Tissue
turnover is also influenced by complex crosstalk across tissues that impact cellular decisions in the adult body.
DNA damage represents one of the earliest manifestations of cellular transformation, and it is a poorly
understood hallmark of cancer. In this proposal, we seek to gain fundamental knowledge about the
mechanisms underlying the survival of stem cells with DNA damage and the gain of uncontrolled proliferation
as they respond to demands of tissue renewal in the adult body. We analyze stem cell behavior in situ and
consider the influence of surrounding tissues. We capitalize on an emerging experimental model system based
on planarian flatworms. Planarians undergo the constant renewal of tissues fueled by stem cells called
neoblasts. DNA double-strand breaks (DSB) are the most dangerous form of DNA damage, and we developed
a strategy to induce a cancer phenotype in planarians that evolve in 12 days. This phenotype is based on the
functional disruption of an evolutionarily conserved tumor suppressor gene PTEN, the second most inactivated
gene in human cancers. Downregulation of PTEN with RNAi in planarians elicits a cancer phenotype
resembling the mammalian counterpart. Cellular transformation becomes noticeable within a few hours after
PTEN inhibition and evasion of apoptosis, cellular over-proliferation, tissue invasion, and the formation of lethal
tumors appear in under two weeks. Strikingly, disrupting neural signals suppress the cancer phenotype offering
unprecedented opportunities to learn how to control cancer. We propose using robust genetics and cell biology
analyses and cutting-edge genomic studies to integrate information from body regions, neural input, and single
cells to reveal multiscale information driving the survival and proliferation of cells with DNA damage during
tissue renewal. The information obtained from these experiments is expected to uncover critical mediators
connecting adult tissue maintenance and its relationship to cancer progression. Our project addresses
fundamental tenets of health and disease by analyzing systemic tissue renewal containing cells that evade
apoptosis and divide with genomic instability.

Public health relevance
Narrative This proposal embodies a multiscale approach to define biological mechanisms underlying the survival and proliferation of cells with DNA damage during tissue renewal, which is critical to a wide range of human clinical problems, including cancer and aging. Our analysis considers cellular decisions in situ as tissues undergo renewal in the complexity of the adult body. Uniquely, we evaluate the development of the most pervasive cancer features in only 12 days and neural signals that can reverse the cancer phenotype.